Mapping cell type specific isoform diversity in the human brain: dissecting mechanisms of alternative splicing in ASD

PROJECT SUMMARY/ABSTRACT
Large-scale RNA sequencing studies have provided remarkable insight into the brain molecular processes that
underlie complex neurodevelopmental disorders like autism spectrum disorder (ASD). Bulk processing of brain
tissue has linked the disruption of alternative splicing, a mechanism by which a gene’s exons and introns are
differentially processed into mRNA isoforms, to the transcriptomic changes seen in ASD. Furthermore, single-
cell and single-nucleus analyses have localized these alterations to pro-inflammatory microglia, astrocytes, and
deep excitatory neuron populations. However, prior splicing analyses were limited to well-annotated isoforms
from short-read data, which account for only a small subset of all isoforms present in the brain transcriptome.
Now, emerging third generation “long-read” sequencing technologies allow for the processing of full-length
transcripts, revealing the full profile of introns and exons for both known and novel gene isoforms. Here, we
propose single nucleus long-read sequencing of over 60 human prefrontal cortex samples, including 33
individuals with a diagnosis of ASD and 30 without such a diagnosis, to fully interrogate the biological function
of isoforms in neuropsychiatric disease. Given the existing evidence of splicing alterations in ASD, and the
growing body of evidence that isoform expression captures the brain’s transcriptomic diversity better than gene
expression, we hypothesize that long-read sequencing will reveal broader transcriptional dysregulation than
previously captured, and that we will localize these changes to highly refined cell subpopulations. Leveraging
long-read technology on our dataset, we will assess the cellular distribution of isoforms in the postnatal human
brain (Aim 1). Next, we will perform case-control differential expression analysis, paired with genomic
enrichment, to identify isoform-level drivers of ASD pathophysiology (Aim 2). Finally, we will examine
correlations between isoforms and identify systems-level regulators of expression, across both control samples
and ASD samples (Aim 3). Altogether, these aims serve to systematically characterize the role of isoform
diversity in the postnatal human brain across both control and ASD populations, aligning with the NIMH’s mission
to uncover the neurobiological basis of brain-related disorders. This proposal will be carried out by Michael
Margolis, an MD/PhD student at UCLA, who will receive comprehensive training in human genetics and
genomics. Mentorship will be provided by Dr. Daniel H. Geschwind as the primary mentor, with additional
mentorship from Dr. Michael J. Gandal, both of whom are experts in the fields of functional genomics and
neurobehavioral genetics.

Public health relevance
PROJECT NARRATIVE Despite mounting genomic and transcriptomic evidence linking alternative splicing to autism spectrum disorder (ASD), the underlying molecular mechanisms remain elusive. This project employs single nucleus long-read sequencing to identify, quantify, and localize full-length isoforms into cell populations of the postnatal prefrontal cortex, in individuals with and without a diagnosis of idiopathic ASD. Gaining insight into how brain-expressed isoforms contribute to cell types, interact in biological pathways, and are dysregulated in the context of ASD, will further our mechanistic understanding of brain function.